Randomized Clinical Trial of a Culturally-Tailored Suite of Smoking Cessation Resources for American Indian Persons

While American Indian (AI) persons have historically used wild or homegrown tobacco for spiritual purposes,
the use of commercially produced tobacco has risen dramatically. Today, smoking-related cancers are as much
as three fold higher among AI persons than White persons. Our preliminary data show that the odds of quitting
smoking among AI persons are 40% lower than White persons. Low engagement with smoking cessation
interventions is considered a major contributor to the disparity in cessation. NCI’s Smokefree program provides a
suite of evidence-based digital resources for smoking cessation, including a website (Smokefree.gov), text
program (Smokefree TXT), smartphone app (QuitGuide), and social media (Smokefree Facebook). These
resources facilitate interaction with one another, have wide reach, and have been shown to increase cessation
in the general population. However, we posit that Smokefree does not meet the needs and cultures of AI
persons and is unlikely to engage and maximize cessation in AI persons. For this reason, through engagement
with tribes and AI-serving clinics and nationally drawn community advisory boards, our team has conducted
preliminary studies to develop Smokefree TXT for Natives and QuitGuide for Natives. Our team also maintains
a social media page, Quit Connections, to provide a community for AI persons during their quit journey. These
culturally aligned resources incorporate Indigenous worldviews and strengths, respect tobacco for spiritual
purposes, integrate smoking triggers such as grief that are common to AI persons, and promote healing
through culture and community connectedness as part of the quit journey. Our next step is to determine to
what extent these culturally aligned resources, when packaged as Smokefree for Natives and supplemented
with a culturally aligned Smokefree.gov, increase smoking cessation among AI persons. Our central
hypothesis is that in AI persons who smoke (PWS) Smokefree for Natives will yield greater smoking
abstinence versus the non-tailored Smokefree. This proposal builds on longstanding collaborations and
employs mixed methodologies including Indigenous practices in engagement, a rigorous clinical trial, and
qualitative interviews. The aims are: Aim 1: To co-create a website, Smokefree.gov for Natives, which will
serve as the landing page for AI-aligned online cessation treatment content and facilitate access to a suite of
culturally aligned digital cessation resources for AI persons; Aim 2: To test the efficacy of Smokefree for
Natives via a remotely conducted randomized controlled trial among American Indian PWS (n=416); Aim 3: To
qualitatively assess perceptions of Smokefree for Natives among AI PWS (n=40) and thematic differences in
response based on demographics and geography. This proposal represents the braiding together of
Indigenous and Western research approaches and represents a logical progression of our engagement efforts
to date. Given that AI persons experience one of the most extreme smoking disparities, a scalable and
culturally aligned smoking cessation intervention for AI persons could have considerable public health impact.

Public health relevance
PROJECT NARRATIVE Given that American Indian (AI) persons experience one of the most extreme smoking inequities, a scalable and culturally-aligned smoking cessation intervention could have a meaningful public health impact in this population. Through engagement with tribes and AI serving clinics and nationally drawn community advisory boards (CABs), our team has conducted multiple preliminary studies to culturally tailor NCI’s Smokefree TXT and QuitGuide smartphone app for AI persons. The present study will culturally-align the final Smokefree resource (Smokefree.gov) and then utilize mixed-methods to evaluate the efficacy of Smokefree for Natives, a suite of culturally-aligned digital cessation resources, among AI persons who smoke.